Gilbert S Greenwald Symposium on Reproduction and Perinatal Research

The Institute for Reproduction and Perinatal Research at the University of Kansas Medical
Center hosts the Annual Gilbert S. Greenwald Symposium on Reproduction and Perinatal Research
in honor of and as a memorial to the life and research career of Gilbert S. Greenwald, Ph.D.; the 2022
Symposium will be the nineteenth. The objective of the annual Symposium is to provide a forum for
all attendees to strengthen and expand individual professional networks, to build knowledge based
both within an individuals research focus and in broader areas of reproduction, to be exposed to new
research techniques and approaches, and to get feedback related to ongoing research projects. The
Symposium provides an important opportunity to strengthen existing and establish new research
collaborations.
Enhancing opportunities for trainees is a key aspect of the symposium. Trainees are provided
the opportunity to participate at all levels; on the organizing committee, suggest, invite, host, and
introduce guest speakers, present their work through elevator talks, poster, or oral presentation, meet
with guest speakers, meet regional researchers, and meet other Midwest regional trainees.
Establishing both communication skills and a networking infrastructure is key to a successful scientific
career and every opportunity, such as the Greenwald Symposium, serves to enhance the overall
training experience.
The Symposium is held over one and a half days and features scientific talks by seven invited
external scientists and seven regional trainees. The Greenwald symposium focuses in the
reproductive sciences and covers topics related to reproduction, development, regenerative medicine,
genetics, epigenetics, stem cell biology, pathologies of the reproductive system, and developmental
origins of disease. We encourage any investigator, faculty, trainee, and laboratory staff to participate
in the Symposium and have approximately 100 attendees each year primarily from Midwest regional
institutions in Kansas, Missouri, Nebraska and Iowa.
We have three key goals with this application; to enhance support of trainees, to address
diversity and inclusion, and to provide an exceptional scientific Symposium. This R13 program will
provide financial support of non-KU trainees for registration and travel costs associated with
participation in the Symposium. The active participation of trainees in scientific meetings is an integral
component of the educational process and we encourage all interested trainees to participate. We
have found deferring costs associated with attending this symposium does facilitate the ability of
trainees to participate and therefore has a role in enhance progression toward a successful career in
research.

Public health relevance
The Greenwald Symposium brings together established scientists and young investigators-in-training to discuss new findings in the fields of reproduction, development, and maternal health. The Symposium functions to further the progress of science and medicine in these focus areas. The Symposium further enhances the training of young investigators.